Multimarker surface signatures of human islet derived extracellular vesicles

We propose an industrial-academic collaboration in response to RFA-DK-21-016 titled “Characterization of Islet-
derived Extracellular Vesicles for Improved Detection, Monitoring, Classification, and Treatment of Type 1
Diabetes”. The objectives are to identify combinations of surface markers that define populations of EV
originating from the major cells of the islets of Langerhans and exocrine pancreatic tissue and to apply novel
technologies for isolating and deeply characterizing these unique EV populations. We will build upon recent
successes at MSD in developing a novel technique for EV surface marker screening and a multimarker
immunoaffinity technique for isolating highly specific EV populations. These techniques will be adapted to the
specific EV populations of the pancreas, which will enable us to observe changes to the EV repertoire related to
pathological events and to identify populations of EVs or specific EV cargo that may serve as a remote biomarker
for islet related events. We will apply our expertise in ultrasensitive ECL-based assays to develop assays that
enable detection of these pancreas-specific EVs from peripheral blood. This proposal combines the technical
expertise of Meso Scale Diagnostics, LLC., with expertise in the biology of islet-derived extracellular vesicles of
our collaborator, Dr. Edward Phelps at the University of Florida.

Public health relevance
We propose an industrial-academic collaboration to characterize islet-derived extracellular vesicles in order to improve detection, monitoring, classification, and treatment of type 1 diabetes. We will use our recently developed and validated technology to identify specific combinations of surface markers on extracellular vesicles. This will enable us not only to measure relative concentrations of subgroups we suspect to be clinically relevant, but also to specifically isolate these subgroups and to measure their content.